Diagnostic Biomarkers of Red Tide (Karenia brevis) Exposure in the Florida Manatee and Sea Turtles by Plasma Proteomics as a Model for Human Exposure

ABSTRACT
In the Gulf of Mexico (GOM), recurring, almost annual blooms of the dinoflagellate Karenia
brevis (known as the Florida red tide) can last for weeks, months, or years, resulting in marine
wildlife mortality events and mass marine wildlife stranding. The negative effects of the Florida
red tide have been linked to a suite of neurotoxins produced by K. brevis collectively known as
the brevetoxins. The brevetoxins cause neurological and respiratory symptoms that can range
from mild to severe depending on the dose. Members of the public are exposed to brevetoxins
during red tide events through inhalation of aerosolized toxins or consumption of contaminated
shellfish. A positive correlation between red tide events and severity and detrimental public health
outcomes has been noted. However, there are no definitive diagnostic criteria for exposure to the
Florida red tide. The Florida manatee and sea turtles are among the wildlife adversely affected
by the Florida red tide. The goal of the proposed work is to identify, quantify, and characterize
alterations in protein abundance in the plasma of manatees and sea turtles that have been
naturally exposed to red tide when compared to healthy animals as a model for human exposure.
This shall be accomplished through bottom-up mass spectrometry (MS)‐based quantitative
proteomic analysis leveraging manatee and sea turtle plasma previously collected during red tide
rescue or during routine health assessments. Successful completion of this work will lead to
diagnostic biomarkers for Florida red tide intoxication in humans.

Public health relevance
PROJECT NARRATIVE Humans exposed to Florida red tide toxins, through the inhalation of aerosols or the consumption of contaminated shellfish, experience respiratory or gastrointestinal symptoms. Emergency room visits due to respiratory symptoms, headache and gastrointestinal distress are increased during red tide events, but currently no definitive diagnostic criteria for red tide exposure exists. Plasma proteomic analysis of model organisms (manatee and sea turtle) naturally exposed to the Florida red tide in their habitat will identify biomarkers of red tide exposure to facilitate accurate diagnoses in humans.